Renewal: Strategies and Methods for Complex Molecule Synthesis

Project Summary/Abstract
The goal of this program is to develop new strategies and methods for the synthesis of
biologically active secondary metabolites (natural products). A significant portion of
our efforts will be dedicated to identifying efficient preparations of these complex
molecules. These compounds and their unique derivatives will serve as novel small
molecules to combat a range of indications associated with cancer as well as
inflammation and pain. Our synthetic studies will lead to new applications of C–H, C–C
and C–N bond functionalization methodology in organic synthesis as well as advancing
the concept of skeletal editing and its application to the preparation of topologically
complex molecules. Finally, working with collaborators, we will gain unique entry into
the use of natural products and their derivatives to perturb biological function and
ultimately provide promising starting points for new therapeutics.

Public health relevance
Project Narrative Finding new and more efficient ways to build complex, bioactive, secondary metabolites (natural products) is important as it may lead to improvements in human health by identifying alternatives to existing medications to address, for example, pain and diseases associated with inflammation. Our goals are to develop new strategies and methods to efficiently construct complex secondary metabolites by functionalizing carbon-hydrogen, carbon-nitrogen and carbon-carbon bonds, which form the core of many organic compounds. Traditionally, these groups have been viewed as inert, especially when they comprise the skeletons of molecules. We will also use carvone, a readily available and sustainable agricultural byproduct, as well as piperidines and heteroaromatics, which are found in many pharmaceuticals and agrochemicals, as starting materials for many of our syntheses. Our efforts will accelerate advances into new chemical space to address human disease.